ADMINISTRATIVE CORE

PROJECT SUMMARY
The Administrative Core will provide oversight, management, and logistical support for our U19 Research Team
and Overall Program, collaborate with the Somatic Cell Genome Editing (SCGE) Translational Coordination and
Dissemination Center (TCDC), and foster engagement with the other Research Teams in the SCGE Consortium.
The Core will ensure that the U19 Research Team is best positioned to successfully achieve the Project annual
milestones, provide administrative support for project and grant management, establish and maintain the
infrastructure for transparent and secure recordkeeping, and facilitate formal and ad hoc meetings within the
U19 Research Team and interactions with the SCGE Consortium and TCDC.